Functional role of serum amyloid A in periapical inflammation (R01 Renew)

Project Summary/Abstract
The long-term goal of our serum amyloid A (SAA) project is to determine the cellular/molecular networks that
regulate the development of infection-induced dental inflammation/bone destruction in the over body fat status.
This renewal application seeks to test a new pathological paradigm that SAA is responsible for obesity and its
associated inflammations via altering the natural antibody (NAb) profile in a high-fat diet (HFD) environment.
Obesity is a global health concern. Obesity exacerbates periapical periodontitis (periapical lesions), leading to a
poor success rate of treatment. Yet, understanding of the detailed pathogenesis of periapical lesions in obese
hosts is still insufficient. SAA is inducible in such as the liver, adipose tissue, and macrophages caused by
inflammation including periapical lesions and obesity. NAb are heterogenous immunoglobulins secreted by B-1
B cells in the absence of prior antigenic experience (e.g. infection). NAb provides immediate and non-specific
protection against infection during the establishment of adaptive immunity over some time period. Also, NAb is
important in the clearance of damaged/apoptotic cells. In opposite, antigens complexed with NAb (immune com-
plexes) may cause tissue injury via complement activation and neutrophil-dependent inflammation.
We have reported that, under normal body fat status, SAA plays a cytokine-like role in the induction of chemo-
taxis, activation of the TLR-NF-kB axis in the development of chronic periapical inflammation, but not in bone
destruction. Next, we examined the role of SAA in periapical lesions in HFD-induced obesity. Obese wild-type
(WT) mice gained >75% larger lesion size vs. lean controls. By contrast, HFD-fed SAA-blocked mice were re-
sistant to both obesity and periapical inflammation, resulted in no body weight gain and almost no periapical
lesions. Significant differences were observed in the gene expression profile of complement and immunoglobulin
variable genes. Non-infected obese-WT mice had a NAb profile characterized by a high titer of IgG1 reactive
with human endodontic pathogens, while HFD-fed SAA-blocked mice showed a high titer of natural polyreactive
IgM. SAA probably plays a hitherto unknown HFD-dependent role in natural antibody response. As complement
genes were locally expressed in obese-WT lesions, SAA may bring causal factors for IgG immune complex injury
only to WT mice in a HFD environment. Taken together, the overarching hypothesis is that SAA plays a unique
HFD-dependent pathologic role in promotion of periapical inflammation and obesity via changing of NAb profile.
We will test the hypothesis through the following Specific Aims.
Aim 1. To examine the effect of SAA on the role of NAb in a HFD environment.
Aim 2. To examine whether SAA leads to IgG immune complex periapical injury in a HFD environment.
Aim 3. To determine the effect of passive NAb transfer on the disease development.
The outcome of this project will lead to a paradigm shift in the pathogenesis of periapical lesions in obesity and
a new therapeutic paradigm in a different manner of conventional therapies.

Public health relevance
Project Narrative The proposed studies apply to public health because they will characterize the newly identified immunomodulatory function of SAA and its role in the exacerbated dental infection/inflammation in obesity. Knowledge gained is expected to inform upon novel means with which to control dental inflammation in overweight/obese individuals. Thus, proposed studies apply to the part of the NIH mission that aims to extend healthy life and reduce the burdens of illness and disability.